Mechanisms of ATAD3A in Regulating the Mitochondrial Genome

ABSTRACT
Mitochondria are dynamic organelles, with the ability to rapidly change their morphology in response to metabolic
or environmental stimuli. These dynamics are particularly important for neuronal function, as mitochondria must
maintain a robust capacity to respond to the physiological and pathological stresses associated with the high
metabolic demands of these cells. Imbalances in mitochondrial morphology that result in excessive mitochondrial
fission (fragmentation) are associated with a wide range of neurological and neurodegenerative diseases, and
mitochondrial fragmentation is a hallmark of ischemia/reperfusion-associated neuronal death. However, we lack
a molecular description of the complex signaling pathways responsible for the rampant fragmentation associated
with disease states and neuronal death. Morphological rearrangements that occur in response to events such
as DNA damage involve communication from the mitochondrial interior to the exterior for recruitment of the
endoplasmic reticulum, we don’t know how these external interactions are communicated. We hypothesize that
the mitochondrial AAA+ protein ATAD3A, which has been shown to play a critical role in regulating mitochondrial
dynamics, serves as an inter-organelle signaling conduit, recognizing mitochondrial DNA damage to cytosolic
proteins as a mediator of mitochondrial DNA stress response. The C-terminal AAA+ domain of ATAD3A is
located within the mitochondrial interior, while its N-terminus is located at the mitochondrial surface, enabling
ATAD3A to establish bilateral interactions with mitochondrial and cytosolic fission/fusion cofactors. Our
hypothesis is further supported by the observation that ATAD3A has been shown to accumulate at
mitochondrion-ER junction sites. Notably, variants of the ATAD3A gene have been identified in patients
exhibiting optic atrophies, fatal congenital pontocerebellar hypoplasia, encephalopathy with cerebellar atrophy,
ataxia, dystonia, and other neurodevelopmental delays and axonal neuropathies, although how these mutations
perturb ATAD3A function or associated interactions is unknown. These studies will provide foundational insights
into how ATAD3A functions as a cross-membrane communication complex, transferring molecular cues across
the outer mitochondrial membrane (OMM) to coordinate mitochondrial fission. We will combine biochemical,
cellular, and structural approaches to confirm the role of ATAD3A in regulating mitochondrial morphology and
dynamics through two aims: In Aim 1 we will characterize the interactions between ATAD3A and mitochondrial
DNA to understand the rules of engagement. Aim 2 will use structure-based experiments to define the specific
molecular mechanisms by which ATAD3A interacts with DNA and allosterically signals DNA damage events to
the cytosol. These studies will provide key insights into the role that ATAD3A plays in dictating morphological
rearrangements, laying the groundwork for a further investigation of how genetic mutations perturb ATAD3A
function and the interactions that drive the mitochondrial fragmentation.

Public health relevance
Narrative Energy-producing organelles called mitochondria are dynamic subcellular entities that can fuse together or divide in response to rapidly changing metabolic requirements of brain cells during development, cognitive function, and other physiological processes. Disruption of these mitochondrial dynamics is linked to a wide range of neurological diseases, and is a hallmark of stroke-related neuronal death. These studies will lay the groundwork to elucidate mechanisms by which an understudied but important mitochondrial protein, ATAD3A, plays a crucial role in mediating mitochondrial division, with the potential to reveal new avenues for neuroprotective therapies.